A compact beam delivery system enabling ultra-fast dose delivery for upright proton therapy

Project Summary/Abstract
This project aims to develop a compact fixed beamline solution incorporating Fixed-Field Alternating Gradient
(FFA) technology and a novel ultra-fast energy degrader for ultra-rapid dose delivery in proton therapy. By
leveraging the unique capabilities of this system, we seek to enhance the quality of proton therapy for patients
and significantly reduce the treatment time and cost of proton therapy. In particular, by delivering each field in a
few seconds, this system will enable effective and more efficient treatment of moving targets. At the same time,
the higher patient throughput and significantly reduced costs of facilities hosting this compact system will improve
the accessibility of proton therapy in the United States and worldwide. Moreover, up to 50% shorter treatment
times will significantly improve patient comfort. The project is composed of three specific aims: (1) Ultra-fast
beam delivery, (2) Beam transport fits within a single treatment room, and (3) Technology validation. Specific
Aim 1 focuses on achieving ultra-fast dose delivery by designing and validating an ultra-fast energy degrader
system capable of rapid beam energy changes. A full-size prototype of the degrader will be engineered by the
industrial partner Pyramid Technical Consultants. This will be followed by the design of the FFA-based beam
transport, enabling efficient energy switching and rapid dose delivery. The FFA lattice will be modeled and
simulated in detail. Pyramid Technical Consultants will also develop a fast pencil beam scanning (PBS) system,
which will be integrated into the beamline design. We will iteratively optimize the entire beam transport solution,
considering clinical requirements for beam quality. Specific Aim 2 will ensure that the beam transport system fits
within a single treatment room. This will involve designing the optics for a beam extraction segment, enabling
compatibility within a compact treatment room the size of a LINAC vault. Two options for the treatment room will
be investigated, including a compact ceiling-mounted synchrotron or a superconducting cyclotron to be paired
with our system. Specific Aim 3 focuses on the validation of the developed technology. Experimental testing will
be conducted to validate the degrader prototype and the fast PBS system, assessing their speed and accuracy
of dose delivery. Furthermore, a down-scaled FFA magnetic beamline will be installed to demonstrate system
feasibility and benchmark output beam parameters against detailed particle transport and tracking simulations.
Successful completion of these aims will pave the way for the translation of the FFA technology combined with
an ultra-fast energy degrader into a pre-commercial prototype of the compact beamline, offering a promising
solution to expedite treatments, improve patient outcomes, and address the limited availability and high cost of
proton therapy.

Public health relevance
Project Narrative Our proposed research aims to revolutionize proton therapy by developing a compact fixed beamline system that enables ultra-fast dose delivery. By reducing single-field delivery time to a few seconds and total treatment time by up to 50% compared to current systems, this technology will enhance patient care, improve treatment quality and increase patient throughput, which, combined with a small facility footprint, will ultimately make proton therapy more accessible and cost-effective. This innovative solution has the potential to significantly advance the field of cancer treatment and improve public health outcomes by optimizing the delivery of proton therapy to a wide range of patients.